Assembly and Secretion of APOB Containing Lipoproteins

DESCRIPTION (provided by applicant): Assembly and Secretion of Apo B Containing Lipoproteins: The dyslipidemia of insulin resistance is very common and is associated with increased assembly and secretion of atherogenic apolipoprotein B (apoB) containing lipoproteins, particularly the triglyceride (TG)-enriched very low density lipoproteins (VLDL). Recently, hepatic steatosis, or non-alcoholic fatty liver disease (NAFLD), has emerged as an additional component of the phenotype. Pharmacologic approaches that would benefit both plasma lipid levels and hepatic fat are limited. A direct path to reducing plasma levels of atherogenic apoB-containing lipoproteins would be inhibition of apoB or TG synthesis and/or assembly into a VLDL. However, efforts to take this path have been associated with severe steatosis e.g., inhibition of microsomal triglyceride transfer protein (MTP) or modest steatosis e.g., inhibition of apoB synthesis using antisense oligonucleotides (ASO). Our preliminary data suggests that autophagy can play an important role in protecting the liver from steatosis while effectively reducing VLDL secretion. Thus, when we treated mice with MTP ASO, significant reductions in VLDL secretion were associated with severe steatosis. However, treatment with apoB ASO led to similar reductions in VLDL secretion but no increased steatosis. Further investigations revealed that apoB ASO treatment stimulated endoplasmic reticulum (ER) autophagy that was associated with increased fatty acid (FA) oxidation. Using this as a foundation, we will test the following hypothesis that reduced availability of apoB in the ER, without concomitant reductions in ER TG, stimulates autophagy, which protects the liver from steatosis with the following aims: Aim 1a. To characterize the effects of inhibiting apoB synthesis, without altering TG delivery to the ER lumen, on hepatic lipid homeostasis and autophagy using mouse models. Aim 1b. To characterize the molecular basis for ER autophagy in cells with inhibited apoB synthesis. We will then extend our studies beyond the specific model of inhibition of apoB synthesis to address the more common states where hepatic lipid metabolism is perturbed: increased FA delivery to the liver, insulin resistance with increased apoB secretion, and perturbations of ER function associated with ER stress. Here we will test the hypothesis that ER autophagy is a mechanism for maintaining homeostasis in the secretory pathway whenever abnormal VLDL assembly and/or secretion lead to ER stress and the UPR with two aims: Aim 2a. To characterize, in greater detail the mechanism whereby FA-induced ER stress and the UPR stimulate autophagy. Aim 2b. To characterize the effects of overexpression of apoB on ER stress, the UPR, and autophagy. The detailed and broad-based studies of autophagy and apoB proposed herein could provide new approaches to reducing VLDL secretion while avoiding hepatic steatosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: Assembly and Secretion of Apo B Containing Lipoproteins: High levels of triglyceride (fat) and the bad LDL cholesterol are commonly present in people with metabolic syndrome or type 2 diabetes mellitus, and add to their risk for developing cardiovascular disease. We are studying how triglyceride and cholesterol are put together in the liver, with a protein called apoB, to make a package (VLDL) that enters the bloodstream and can itself get into the artier wall or, after delivery the triglyceride to fat tissue for storage, ecome LDL. Recently, more and more people with high levels of blood triglyceride and bad cholesterol have been identified to also have fatty liver. The link between fatty liver and too much fat in the blood is under intensive examination and our studies hope to shed new light on this problem. If we are successful at increasing our knowledge about these issues, we may find ways to reduce both fatty liver and heart disease. __SpecificAimsTextDelimiter__ Specific Aims: For over 20 years, our group, in collaboration with Ed Fisher's group, has been a leader in the detailed characterization of the assembly and secretion of very low density lipoproteins (VLDL) 1-3. We were the first to demonstrate that availability of lipids in the endoplasmic reticulum (ER) regulates the cotranslational ubiquitinylation and proteasomal degradation of apolipoprotein B (apoB) 4-6; that lipid-induced ER stress and the uncoupled protein response (UPR) increase apoB degradation and limit VLDL secretion 7; and that autophagy plays a role in the ability of at least some fatty acids (FAs) to reduce apoB secretion 8, 9. Relevant to this application is an early study we conducted indicating both co- and post-translational degradation of apoB when transport from ER to Golgi was inhibited 10, and our more recent work demonstrating that FA induced UPR was associated with both proteasomal and non-proteasomal degradation 7. In this application, we propose a series of studies that build on our very novel and exciting unpublished data demonstrating that inhibition of apoB synthesis results in ER autophagy, a response that protects the liver from steatosis in the face of markedly reduced VLDL secretion. These results, support the concept that direct inhibition of apoB synthesis may not result in as much severe steatosis as expected 11-13. More importantly they serve as a base from which we will focus on the general role of autophagy in the regulation of lipid and apoB metabolism in the secretory pathway. Thus, we will extend our prior published work on the effects of FA-induced ER stress on the assembly and secretion of apoB-lipoproteins, examining links between ER stress and autophagy. We will also utilize older models that we developed, such as the apoB/BATless mouse, to examine the integrated response of hepatocytes to environments in which apoB and TG are mismatched in the ER or where the secretory pathway is perturbed. We will examine, in detail, the relationships between ER stress and autophagy 14-16, and between ubiquitinylation, proteasomal degradation, and autophagy 17, 18. We believe, based on our prior experience, and the extensive preliminary data we have developed, that we are optimally positioned to extend our previous, detailed studies of the itinerary of apoB within the secretory pathway, focusing on autophagy as a component of this itinerary that will enable therapeutic strategies whereby VLDL secretion can be reduced without causing accumulation of hepatic triglycerides (TG). Our studies should provide insights regarding targets for drugs that will reduce plasma levels of atherogenic apoB lipoproteins with no or only modest effects on hepatic steatosis. Hypothesis 1: Reduced availability of apoB in the ER, without concomitant reductions in ER TG, stimulates autophagy, which protects the liver from steatosis. Aim 1a. To characterize the effects of inhibiting apoB synthesis, without altering TG delivery to the ER lumen, on hepatic lipid homeostasis and autophagy using mouse models. We will extend our exiting, large body of preliminary data developed with an antisense oligonucleotide against apoB to characterize in detail the development of ER autophagy. Aim 1b. To characterize the molecular basis for ER autophagy in cells with inhibited apoB synthesis. We will use our recently developed cell models of siRNA apoB knockdown to probe the molecular basis for ER autophagy in response to mismatched apoB and TG in the ER. Hypothesis 2: ER autophagy is a mechanism for maintaining homeostasis in the secretory pathway whenever abnormal VLDL assembly and/or secretion lead to ER stress and the UPR. Aim 2a. To characterize, in greater detail the mechanism whereby FA-induced ER stress and the UPR stimulate autophagy. We will build upon our published work on FA induced ER stress and the UPR to determine how and what type of autophagy develops in response to these metabolic perturbations. Aim 2b. To characterize the effects of perturbations of the assembly and secretion of apoB on ER stress, the UPR, and autophagy. We will expand the types of perturbations to ER function and VLDL secretion to examine the mechanisms whereby the cell maintains lipid homeostasis through the stimulation of autophagy.